Brain-gut-retina axis in diabetic retinopathy

Summary Abstract
This application puts for the notion of a brain-gut- retinal axis that becomes dysfunctional in diabetic
retinopathy (DR). The innate immune system has been strongly implicated in the pathogenesis of DR,
but less is known about the role of the adaptive immune system. At the interface of these two systems is
a critical population of cells, Th17 cells, that typically reside in the gut during health. Th17 cells have
homeostatic properties, mediating host defense against bacterial and fungal infections; however, it
remains unclear how intestinal Th17 cells integrate diverse signals into a set of cellular programs that
allow them to maintain tissue homeostasis yet also become pathogenic, serving as primary drivers of
tissue inflammation. We have identified a critical role of somatostatinergic neurons in the paraventricular
nucleus of the hypothalamus (PVN) in regulation of immune function through “loss of function” studies
and “gain of function studies. SST expression is dramatically reduced in the PVN of diabetic animals.
Hypothalamic dysfunction, as seen in diabetes, has the capacity to induce injury directly through
hyperactivation of sympathetic nerves. Based on preliminary and published data, we put for the
hypothesis that: Diabetes-induced loss of inhibitory SST neurons in the PVN drives increased autonomic
input to the intestine shifting Th17 cells from a homeostatic to a pathologic state. Pathologic Th17 cells
leave the intestine and traffic to areas of tissue injury such as the retina in DR. In the retina the
pathologic Th17 cells secrete proinflammatory cytokines that recruitment innate immune cells into the
retina exacerbating DR. To examine this hypothesis, we propose the following aims: Aim 1: To test if
impaired function of hypothalamic SST neurons in diabetes contributes to hyperactivity of autonomic
efferents to the gut and increases activation of enteric neurons. Aim 2: To selectively ablate SST PVN
neurons (in the absence of diabetes) and evaluate if this results in increased autonomic input to the gut
and a shift from “homeostatic” Th17 cells to a “pathogenic” Th17 cells that migrate to the retina and
recruit circulating immune cells. Aim 3: To determine if maintaining hypothalamic SST levels at
nondiabetic levels in diabetic mice will preserve the function of homeostatic Th17 cells in the gut and
prevent their recruitment to the retina delaying the development of DR. Impact: SST analogues may
provide an important complementary strategy for DR management by preventing increased sympathetic
drive to the gut and Th17 cell dysfunction.

Public health relevance
Project Narrative We are testing the hypothesis that the brain-gut-retina communicate through the regulation of immune cell function and that in diabetic retinopathy this communication is disturbed. Specifically, diabetes induces loss of expression of key neurotransmitters (somatostatin) in special centers in the brain and this loss of somatostatin results in the intestine, an immune tissue, becoming hyperstimulated. We postulate that this hyperstimulation results in the intestine generating pathological cells that leave the intestine, enter the circulation and go to the retina where they accelerate the development of diabetic retinopathy.